Metabolomics

ABSTRACT: Metabolomics Core
The DRC Metabolomics Core provides rigorous mass spectrometry (MS) analyses to DRC Investigators that
include quantification as well as structural characterization of diabetes-related biomolecules. The Core
increases efficiency and cost effectiveness by providing centralized, standardized analyses to study molecular
mechanisms of the pathogenesis of diabetes, its risk factors, and its complications. A major goal of the core is
to promote use of MS methods in diabetes research by efforts in training, collaboration, development, service,
and dissemination. Specific objectives of the Core are: 1) to provide and maintain functional MS systems for
diabetes-related studies; 2) to consult with DRC investigators on application of MS to advance their research
programs; 3) to perform service-related MS analyses for diabetes investigators, such as quantifying target
analytes, obtaining spectra for structural identification, and assisting with mass spectra interpretation; 4) to
develop new MS methods; and 5) to provide training to students and fellows in principles and use of MS
systems. The services offered by the Metabolomics Core reflect the evolving bioanalytical needs of DRC
investigators, including targeted metabolomic services to broadly survey multiple metabolic pathways and
quantify pathway metabolites, in addition to high-throughput, quality-controlled measurements of analytes in
large sample sets from clincal studies.

Public health relevance
PROJECT NARRATIVE: Metabolomics Core Diabetes-related research requires the ability to analyze molecules reflecting the metabolism of glucose, cholesterol, fatty acids, and other key mediators of diabetes and its complications. The DRC Metabolomics Core provides DRC members with access to equipment and expertise allowing characterization of relevant metabolic pathways and quantification of important metabolites relevant to diabetes. The goal of the Metabolomics Core is to promote use of sophisticated analytical methods in diabetes research through support of training, collaboration, development, service, and dissemination.